Personalized Immunomonitoring to Understand Juvenile Dermatomyositis

Summary JDM R01; PIs: Pascual, V. & Wilson, P.
Juvenile Dermatomyositis (JDM) is the most common pediatric idiopathic inflammatory myopathy. It typically
presents with a pathognomonic rash and/or proximal muscle weakness that interferes with activities of daily living
and may severely impair the patient’s quality of life. JDM is a systemic autoimmune disease as, in addition to
the skin and muscle, organs such as the lungs, heart, and intestines can be involved. Characteristic immune
findings include the presence of autoantibodies, increased interferon (IFN) activity and infiltration of immune cells
across involved tissues. In addition, JDM is considered a “vasculopathy”, as endothelial cell loss and/or
dysfunction is a pathognomonic feature of the disease. The outlook for children affected by JDM has improved
in the past fifty years, but significant gaps remain around disease pathogenesis. As a result, therapy continues
to rely on non-specific immunosuppression. Furthermore, sensitive, specific and minimally invasive methods to
diagnose, measure disease activity and predict JDM disease course are not available.
As most systemic autoimmune diseases, JDM is clinically and molecularly heterogeneous. Thus, a variety of
disease phenotypes are linked to the presence of myositis-specific (MSA) autoantibodies. Differences in
transitional and memory B cell and helper T cell subpopulation frequencies have been reported, but the
mechanisms leading to autoantibody development are not known. We recently identified expansions of
CXCR5low/neg CD27+ memory B cells and Th2 cells in JDM patient’s blood in correlation with IFN-stimulated gene
(ISG) signatures and with muscle weakness. We hypothesize that these cells contribute to JDM autoreactivity
and represent a valuable biomarker of disease activity (DA). Single cell (SC) transcriptional profiling of JDM
PBMCs has permitted us to confirm and extend these observations and to gain insights into innate and adaptive
immune alterations that correlate with DA. Here, we will leverage our preliminary cross-sectional findings through
longitudinal systems-level immune monitoring of patients and in-depth characterization of MSA responses, as
well as spatial analyses of involved muscle. Importantly, this project will capitalize on a very well characterized
longitudinal pediatric JDM cohort, resources developed over twenty years to study the human immune system,
and an exclusive group of co-investigators with complementary expertise. In order to achieve these goals, we
propose the following aims: a) to assess longitudinally and at the SC level, the PBMC and antigen-specific B/T
cell compartments of JDM patients stratified according to i) organ involvement, ii) autoantibody specificities, and
iii) response to therapy; b) to characterize MSA responses through SC cloning, expression and repertoire
analyses and test their function and pathogenic potential; and c) to map the heterogeneity of muscle resident
and infiltrating immune cells using state-of-the-art spatial transcriptomic and proteomic tools.
Altogether, these studies will bring important clues to understand JDM pathogenesis and disease heterogeneity
and will inform novel and personalized therapeutic approaches.

Public health relevance
Narrative JDM R01; PI’s: Pascual, V. & Wilson P. Juvenile Dermatomyositis (JDM) is a heterogeneous systemic autoimmune disease with suboptimal responses to therapy and long-term morbidity. Dysregulation of adaptive immunity and development of autoantibodies are hallmarks of the disease, but the contribution of specific B and T cell subsets and the role of innate immunity remain elusive. This proposal will address major knowledge gaps in JDM pathogenesis, namely a) understanding pathogenic drivers of disease; b) finding biomarkers to follow patients in the clinical setting; c) characterizing autoantibody targets and epitopes; and d) integrating blood and tissue studies to stratify patients into well-defined molecular subgroups toward the goal of delivering personalized and efficient patient care.